FFA Metabolism in Different Types of Human Obesity

Project Summary/Abstract
The long-term objective of our research is to understand the mechanisms by which obesity, and
specifically upper body obesity (UBO), causes insulin resistance and the other health problems such as Type 2
Diabetes. Our focus is on the release of free fatty acids (FFA) from adipose tissue lipolysis in humans and how
those FFA affect the functioning of other tissues (lipotoxicity). The specific aims of this proposal are to: 1)
Determine whether impaired insulin-induced suppression of lipolysis (as measured by IC50) is related to the
above mentioned lipolysis proteins in groups of volunteers known to vary widely with regards to abdominal
adipocyte size and regulation of adipose tissue lipolysis; 2) Determine whether the improved insulin regulation
of lipolysis resulting from treatment with the PPARγ agonist pioglitazone, with or without weight loss, can be
linked to specific changes in sets of PPARγ-responsive adipocyte lipolysis proteins in UBO adults; 3)
Determine whether the adipose inflammatory cell and cytokine content in Class III obesity is related to lipolysis
insulin resistance and, if so, whether sustained, substantial weight loss one year following bariatric surgery
reduces inflammation in parallel with improved insulin regulation of lipolysis. We will measure of insulin-
regulated adipose tissue lipolysis in vivo and assess adipocyte lipolysis proteins, inflammation and insulin
signaling in obese humans with widely varying degrees of insulin resistance. Our hypothesis is that proteins
involved in the final steps of the regulation of lipolysis are altered in humans with large fat cells, and that these
alterations are responsible for adipose insulin resistance. Combined, we believe these studies will offer insights
as to why adipose tissue lipolysis is abnormal in some obesity phenotypes and provide information on what
therapeutic strategies to treat adipose insulin resistance are most compelling.

Public health relevance
Project Narrative We wish to understand why people who gain weight primarily in the abdominal area are more prone to illnesses such as diabetes. We know that fat tissue under the skin in the abdominal area releases excess fat release into the bloodstream, which then effects how the rest of our body is able to metabolize sugars. The experiments we propose will measure whether certain proteins in fat cells are present in abnormal amounts and whether this alters the ability of fat cells to respond to the body's signals that are supposed to reduce the release of fats into the bloodstream.